The Role of Adaptor Protein Disabled-2 in Maintaining Endothelial Cell Function in Atherosclerosis

PROJECT SUMMARY/ABSTRACT
Cardiovascular diseases are often associated with impaired responses from the endothelium, which results
from endothelial cell dysfunction. Endothelial cell dysfunction causes endothelial activation and sub-endothelial
retention of modified low-density lipoprotein (LDL) particles, leading to the recruitment of immune and
inflammatory cells to the intima, which initiate atheromatous plaque build-up. Of major importance, transitioning
from a stable to vulnerable atheroma fuels myocardial infarction and stroke, posing enormous health
challenges with the highest morbidity and mortality in the United States. New research is urgently needed to
uncover critical pathophysiological mechanisms and identify molecules that limit endothelial dysfunction. This
has led us to determine a novel and indispensable role for an endocytic adaptor protein called Disabled
homolog 2 (Dab2), which participates in clathrin-mediated endocytosis in addition to moonlighting as a tumor
suppressor. Curiously, little to no prior work has been done to identify its role in endothelial cells. Our pilot
assessment has revealed that Dab2 levels are strikingly decreased in the atherosclerotic endothelium of
mouse and human fatty streaks—suggesting a protective role in atherogenesis. As the atheroprotective effects
of Dab2 are poorly understood in the context of endothelial cells, we created endothelial-specific inducible
Dab2 knockout mice (EC-iDab2KO) and bred them to an ApoE-null background (EC-Dab2iKO/ApoE-/-).
Western diet-fed EC-iDab2KO/ApoE-/- mice exhibit heightened arterial inflammation and more severe plaque
formation; yet, the molecular mechanisms and signaling pathways that direct Dab2 to combat arterial
inflammation are completely unknown. Our initial investigation indicates that Dab2 expression is upregulated in
response to atheroprotective flow, and Dab2 deficiency in human aortic endothelial cells suppresses
endothelial nitric oxide synthase (eNOS) activation. To ensure the clinical relevance of our work, we are
employing an innovative nanotechnology to deliver Dab2 mRNA to the atherogenic endothelium using an
engineered nanoparticle to restore Dab2 function. This technology increases Dab2 expression in the atheroma,
which restrains plaque progression in ApoE-/- mice. The goal of this proposal is to define the signaling
mechanisms underpinning the essential role of Dab2 in protecting the atherogenic endothelium. To this end,
we seek to determine molecular mechanisms by which Dab2 curbs arterial inflammation and activates eNOS in
endothelial cells. Our possession of innovative targeting reagents and novel animal models will greatly facilitate
our paradigm-shifting endeavor. If fruitful, the exciting work proposed in our application will provide a
foundation for the development of new treatments to benefit patients at-risk for heart attacks and strokes.

Public health relevance
PROJECT NARRATIVE Our long-term goal is to understand the molecular and cellular events that underlie the formation and growth of unstable atherosclerotic plaques in blood vessels, which can cause heart attacks and strokes. These medical conditions represent the leading cause of death worldwide and are highly-relevant to the mission of the NIH. In particular, we are investigating how arterial inflammation and endothelial cell dysfunction contribute to the formation of vulnerable plaques with the goal of identifying new therapeutic targets to treat atherosclerosis.